Mechanisms of Economic Decisions in Mice

Economic choice behavior is specifically disrupted in a variety of mental and neurological disorders including
frontotemporal dementia, major depression and drug addiction. Thus to better understand the origins of these
disorders and to pave the way for treatments it is critical to understand the neural underpinnings of this
behavior. Evidence from neurophysiology in non-human primates, functional imaging in humans and lesions in
multiple species establishes a link between economic choice and the orbitofrontal cortex (OFC). In particular,
previous research in the PI’s lab examined the activity of single neurons in the OFC of monkeys choosing
between different liquid rewards. This work identified three groups of cells encoding the identity and subjective
values of offered and chosen goods. The variables encoded in OFC capture both the input and the output of
the choice process, suggesting that the cell groups identified in this area constitute the building blocks of a
circuit in which decisions are formed. A series of theoretical and experimental results support this hypothesis,
but many aspects of this circuit are poorly understood. For example, we don’t know whether different cell
groups identified in OFC correspond to different anatomical cell types, whether they populate different cortical
layers, and how they are connected with each other and with other brain regions. To address these and related
questions, we brought our investigation to a genetically tractable species – the mouse. In a first study, we
developed a mouse model of economic choice behavior and we demonstrated that optogenetic inactivation of
the lateral orbital area (LO) disrupts choices (Kuwabara et al, eLife, 2020). In preparation for this proposal, we
developed a protocol for two-photon (2P) calcium (Ca2+) imaging of area LO in mice performing choices. We
thus identified three groups of neurons analogous to those previously found in primates. The overarching goal
of this proposal is to link the functional cell groups identified in LO to anatomically defined cell types. To do so,
we will combine 2P Ca2+ imaging with genetic markers and viral tracing. In a series of experiments, we will
assess (Aim 1) whether different cell groups defined in relation to behavior reside preferentially in different
layers, (Aim 2) whether different cell groups are differentially connected with sensory and/or motor regions,
and (Aim 3) the relation between functional cell groups and inhibitory interneurons. In addition, (Aim 4) we will
use Granger causality analysis to assess the effective connectivity between different cell groups.
This is a collaboration between Dr. Padoa-Schioppa (PI), an expert in economic decisions, and Dr. Holy (co-I),
an expert in mouse olfaction and optical imaging. Our collaboration has been ongoing for several years and we
already published a first report. The experiments proposed here will break new ground and extend previous
work in a new and promising direction. If successful, our research will shed light on a fundamental brain
function. It will also lay the ground to pursue numerous other questions. Preliminary results obtained for each
specific aim demonstrate high likelihood of success.
1

Public health relevance
Economic choice is the behavior observed when individuals choose between multiple available options based on subjective preference -- for example out of a restaurant menu. It is specifically impaired in various clinical conditions including schizophrenia and drug addiction. The overarching goal is to dissect the neural circuit underlying economic decisions using genetic tools in mice. 1